Development of Streamed Ion Deposition for Efficient Plasmid DNA Delivery

DESCRIPTION (provided by applicant): This application proposes to explore a novel DNA delivery platform for skin that utilizes a stream of ions generated in plasma (charged gas stream) to facilitate the uptake of DNA. This new physical DNA delivery technology differs from other technologies in that it does not utilize chemical or biological agents. It also differs from other physical DNA delivery methods in that it does not require contact between any devices and the skin;therefore, it is noninvasive. Preliminary studies have shown that it is possible to deliver foreign molecules to cells in vitro and plasmid DNA to normal mouse skin in vivo without the adverse stimulation noted when other electrical methodologies are used. Based on these findings, the hypothesis of this proposal is that streamed ion deposition can be used for efficient DNA delivery to skin. This hypothesis will be tested by performing specific aims that characterize its capacity to deliver plasmids encoding reporter molecules. It will also be tested with respect to delivering plasmid encoding an antigen and a secreted protein to explore the methods capacity for prophylactic and therapeutic use. PUBLIC HEALTH RELEVANCE: This study is relevant to public health as the results may lead to treatments for many types of diseases that require the secretion of a therapeutic protein into the blood. In addition, it may lead to a better means of applying DNA vaccines against infectious diseases.

Public health relevance
PROJECT NARRATIVE: This study is relevant to public health as the results may lead to treatments for many types of diseases that require the secretion of a therapeutic protein into the blood. In addition, it may lead to a better means of applying DNA vaccines against infectious diseases.